Drug Interactions Involving Second-generation Antipsychotic Agents Leading to Sudden Cardiac Arrest

Schizophrenia affects approximately 1.1% of the population, or approximately 3.5 million Americans. The life expectancy
of persons with schizophrenia is 10-25 years less than that of the general population, and has not improved in recent
decades. Sudden cardiac arrest (SCA) and ventricular arrhythmia (VA), which account for 8-10% of all deaths in this
population, is three times as common among those with than without schizophrenia. The most clearly established risk
factor for SCA/VA in persons with schizophrenia is the use of antipsychotic agents, and this risk is dose-dependent.
Second-generation antipsychotic agents (SGAs) are the most common treatment for schizophrenia, and are also used for
other common mental health conditions including bipolar disorder, major depressive disorder, and psychosis/agitation
associated with dementia. The prevalence of current antipsychotic drug use in US adults is 1.6%, or 3.8 million adults. A
recent meta-analysis found that several widely used SGAs are associated with an elevated risk of SCA/VA. Given the high
prevalence of polypharmacy in persons with schizophrenia and other mental health conditions, and the high potential
for drug interactions in persons taking SGAs, clinicians badly need evidence-based guidance on which drugs do and do
not increase the risk of SCA/VA in persons taking specific SGAs. Unfortunately, almost all available evidence about the
health effects of potential DDIs involving SGAs comes from either 1) spontaneously reported adverse drug events, which
provide limited evidence for causation because of their anecdotal nature, or from 2) pharmacokinetic studies of serum
concentrations of SGAs, which include few subjects and do not examine health end-points. A more rigorous approach to
identifying and elucidating drug interactions will help to identify drug-drug pairs that truly increase the risk of SCA/VA,
and improve the safety of pharmacotherapy provided to persons with schizophrenia and other mental health conditions.
To address these critical knowledge gaps about which drugs should and should not be avoided in persons receiving
commonly used second generation antipsychotic drugs, we will perform high-throughput pharmacoepidemiology
screening to identify drugs that may increase the rate of out-of-hospital SCA/VA in persons taking commonly used
second-generation antipsychotic agents. Then, in two independent validation populations, we will conduct hypothesis-
driven etiologic pharmacoepidemiology studies to either confirm or refute high-priority potential drug interactions, and
elucidate factors that place patients at increased risk of out-of-hospital SCA/VA associated with specific drug pairs. The
results of this research will provide drug interaction compendia editors with valid, actionable evidence that will allow
them to warn clinicians about truly risky drug combinations. Of equal importance, this research will allow clinicians to be
relieved of unnecessary and burdensome alerts about drug combinations that can actually be administered safely. We
further propose to enhance the impact of our research by disseminating key findings through our ongoing series of
webinars, newsletters, and videos that we produce for our established stakeholder group of editors and curators of drug
interaction compendia and computerized decision support systems.

Public health relevance
This study will develop valid, actionable evidence about which drugs, when given together with second-generation antipsychotic agents, lead to an increased rate of out-of-hospital sudden cardiac arrest and ventricular arrhythmia. This evidence will improve the safety of drug therapy for millions of persons with mental health conditions who take second generation antipsychotic agents.